Therapeutic target discovery in ADSP data via comprehensive whole-genome analysis incorporating ethnic diversity and systems approaches

Project Summary/Abstract:
The Alzheimer Disease Sequencing Project (ADSP) seeks to identify new genomic variants contributing to
increased risk for and protection from Alzheimer's Disease in multi-ethnic populations, and to identify new
pathways for disease treatment and prevention. Whole genome and whole exome sequencing data (WGS and
WES) are available from ADSP Discovery and Discovery-Extension Phases and WGS in diverse ethnic groups
will be generated for the Follow-up Study (FUS). The investigators of this proposal have diverse but
complementary expertise across the range of bioinformatics, applied statistics and methodological
development, admixture and ethnic diversity, rare variant association, network modeling, preclinical validation
of targets, and clinical expertise in AD and have been involved in the ADSP since its inception. Further they
bring expertise on endophenotypes and additional WGS data through their role within the CHARGE (Cohorts
for Heart and Aging Research in Genomic Epidemiology) and TOPMed (Trans-Omics for Precision Medicine)
consortia. We now propose the following aims to meet ADSP goals. Aim 1: To fully characterize known AD loci
and to identify novel protective and risk variants for AD by exploiting the full range of genetic variability
revealed by WGS including single nucleotide polymorphisms, small insertion/deletions, and structural variants.
Analyses will include expanded association analyses of AD and endophenotypes, identification of novel
protective variants via carefully selected “Wellderly” samples, and integration of findings across analyses. Aim
2: To leverage ethnically-diverse and admixed populations to identify novel variants for AD and
endophenotypes. This will be achieved by estimating and accounting for global-scale population structure in
association analyses across the three phases of ADSP. We additionally propose to perform admixture
mapping in samples of admixed ancestry and to perform ethnic-specific analyses and trans-ethnic meta-
analyses. Aim 2 analyses will be performed for AD, AD endophenotypes, and Wellderly status. Aim 3: To
functionally characterize genes, gene networks, and systems, via bioinformatics and omics integrative
analyses to identify putative therapeutic targets. The investigators will work closely with the Accelerating
Medicines Partnership (AMP) projects. We propose to use a combination of bioinformatics tools and analysis
of “omics” data, including DNA methylation, gene expression, miRNA and metabolomics data within AMP and
in the CHARGE cohorts to predict function of specific variants or groups of variants, to apply network
approaches across gene sets, to utilize a systems approach to understand the ADSP sequencing data in the
larger context of human biology and to identify putative therapeutic targets. Our proposal provides a
comprehensive, integrated plan, which we will implement within the existing ADSP infrastructure and in
coordination with ADSP investigators.

Public health relevance
Project Narrative This proposal seeks to analyze existing genetic sequencing data generated as part of the Alzheimer's Disease Sequencing Project (ADSP) and specifically the ADSP Follow-up Study (FUS) with the goal of identifying genes and specific changes within those genes that either confer risk for Alzheimer's Disease or provide protection from Alzheimer's Disease. Analytic challenges, which will be met by application of innovative methods, include analysis of whole genome sequencing data and appropriately accounting for population structure across European ancestry, Hispanic, and African American participants.